The Evidence Project: Systematic Reviews of Critical HIV Interventions, and Disruption in HIV Services from COVID-19 in LMIC

PROJECT SUMMARY / ABSTRACT
Abstract:
Despite the vast and ever-growing scientific literature on the efficacy of behavior, social, and structural
interventions, interpreting the scientific literature is challenging. Identifying relevant studies is time intensive.
The quality of research from published reports requires careful analysis. There are conflicting findings across
studies. Metrics and study designs used across studies are typically inconsistent. Pooling results across
studies also requires advanced statistical techniques. The state-of-the-art strategy to address these challenges
is to use systematic reviews and meta-analyses to analyze and interpret the effects of interventions evidenced
with research across multiple studies. In the prposed study we will conduct systematic reviews and meta-
analyses on studies from LMIC that focus on behavioral, social, or structural interventions. There are three key
areas we will analyze: (1) interventions designed to support linkage, retention, and adherence to ART and
PrEP with a focus on modes of service delivery; (2) interventions that integrate non-HIV health issues with HIV-
specific health issues; and (3) assessing the impact of the COVID-19 epidemic on HIV-related care and
prevention in LMIC. In addition, we will add to our rigorous data extraction information on both the theoretical
basis of the interventions under consideration, as well as data on the implementation characteristics of each
intervention. Data extraction on implementation characteristics and theory will also be done retrospectively for
all 435 studies we have previously reviewed and added to our data repository.

Public health relevance
PROJECT NARRATIVE The US Government is the leading funder of HIV prevention and care in low- and middle-income countries, and there is a need to allocate resources with evidence-based strategies proven to work in the most efficient manner possible. This project will provide needed policy and program advice on what is working in global HIV prevention based on the strength of evidence from the scientific literature using systematic reviews and meta- analyses to address the most salient needs emerging in the field, including the impact of COVID-19 on HIV services. The study will provide essential information to guide intervention programming to improve the public health impact of US investments in global HIV/AIDS prevention and control.